Intersecting roles for lineage and sex in the development of innate behavior circuits

Project Summary/Abstract
Sexually reproducing animals perform innate sexually dimorphic behaviors that are important for their
reproductive success. Sex differentiation of the brain and behavior is established through the action of master
regulators that work downstream of sex determination factors. In mammals, nuclear hormone receptors fill this
role; in insects, neural sex differentiation is mediated by the male-specific transcription factor Fruitless (FruM).
The importance of these master regulators in sexual differentiation of the brain and behavior is well established.
However, how a subset of neurons become specified for their expression and function is poorly understood. To
explore this, we use the Drosophila melanogaster as a model. In both sexes, fruitless is transcribed in a subset
of neurons that wire together into sexually differentiated circuits regulating social behaviors. However, FruM
protein is only translated in the male. Most D. melanogaster central brain neurons are born from progenitor cells
that produce neurons in a pair-wise fashion, producing two distinct hemilineages. Diverse fruitless neurons are
contained in at least 60 different hemilineages that make up the D. melanogaster central brain along with sister
cells that do not express fruitless. This suggests that hemilineage identity is an important factor for the
specification of fruitless transcription and for the impact of Fruitless protein. Using scRNA-seq to study fruitless
expressing neurons in the context of their neuronal hemilineages, I identified the nuclear receptor dissatisfaction
as being enriched in the entire hemilineage that contains the fruitless-expressing mAL neurons (Medially located,
just above Antennal Lobe), including sister neurons that do not express fruitless. Interestingly, dissatisfaction
has previously been shown to be important for sex-specific behaviors and my preliminary data also shows it is
important for the overall development of this hemilineage. Here, we will test how Dissatisfaction impacts
development of this hemilineage and how this sex-shared factor impacts the sex differentiation process in circuits
which control social behaviors. The work proposed in this application will elucidate how a neuron’s lineage origin
interacts with the sex differentiation process to specify its circuit function during development.
This F99/K00 proposal describes the training and mentorship the applicant will acquire to help transition
her to an independent research position at an academic institution. The applicant will receive the necessary
training and mentorship from her sponsor and co-sponsor to successfully complete the experiments outlined in
this proposal and to transition her to a strong postdoctoral lab. She will also have additional support from her
thesis committee members, the wider neuroscience University of Michigan community and from experts from
other institutions. This proposal also outlines additional training in scientific research and professional
development that will be pivotal for her scientific growth and for achieving her long-term career goals.

Public health relevance
Project Narrative Animals show innate sex differences in their social behavior. Underlying these behaviors are complex neuronal circuits made up of only a small percentage of the neurons in the brain that develop differently between males and females. Here we are asking how those neurons are programmed for their wiring and function during development.